Roybal Translational Research Center to Promote Context-Specific Caregiving of Community-Dwelling Persons Living with Alzheimer's Disease or Related Disorders

Abstract. The goal of the proposed Roybal Translational Research Center is to provide support to investiga-
tors across the nation to conduct NIH Stage I-III intervention research that will enhance the context-specific
role-mastery of informal caregivers of persons living with Alzheimer’s disease and similar illnesses. We look to
the future: by 2050, as many as 20 million Americans will be living with these illnesses, and the number of
informal caregivers will expand to 40-50 million. Informal caregiving is the key to the quality of life and
continued community living of persons living with Alzheimer’s and similar illnesses; it is also a bulwark against
rising health care costs. Our Center rests on the premise that informal caregiving is not one homogenous entity
but is context-specific. As the U.S. continues to experience major reconfigurations in its social and
demographic composition (we will, for instance, be a “minority majority” country by 2043), we expect caregiving
to occur in an ever-increasing set of heterogeneous contexts. These contexts are framed by various illness
conditions, family, cultural, or social caregiving situations, geographical location, and care recipients’
transitions through care settings, especially the acute setting. The two pilots proposed in this application
exemplify topics shaped by heterogeneous contexts: one focuses on caregiving for persons with Primary
Progressive Aphasia, the other on the situation of caregivers from a sexual-orientation minority group. Our
Center’s second assertion is that interventions developed to address these contexts must be designed with the
involvement of caregivers/consumers from within these contexts. Our Center builds on substantial contributed
support from our institution and a set of existing relationships with key national networks of Alzheimer’s and
caregiver researchers, centers and investigators engaged in geriatrics and gerontology research, and centers
and organizations focused on promoting diversity and the voice of the consumer. Our Center will provide a set
of integrated processes and a method of “design thinking” (product-focused facilitated multi-perspective
discourse) embedded in our Design Studio that creates a pipeline leading to increasingly sophisticated
caregiver interventions. The Center incorporates an outreach function to attract and engage investigators and
consumers in discussions about and design of interventions. It includes a function for mentoring interested
investigators in the development of effective pilot proposals and a rigorous method for selecting especially
meritorious proposals. In the implementation phase of supported pilots, the Center’s Pilot Core assumes a
mentoring and monitoring role to ensure pilot success, and the Administrative Core provides structure to
ensure the responsible conduct of the pilots. The Pilot Core and Design Studio work with pilot investigators to
craft and follow an individual plan by which a proposal for the next stage of development for the pilot is created
to seek support from us or other sources. The inter-related activities of the Center will enable it to pursue a
second overall aim, the continued advancement of the science of intervention development.

Public health relevance
Public Health Relevance. The proposed Center addresses the need to strengthen the capacity of informal caregivers of persons living with Alzheimer's and similar illnesses to provide guidance and care to those individuals and, therefore, enable them to live in the community and not in institutional settings for as long as possible. Addressing the need to promote caregiving mastery in heterogeneous caregiving contexts is central to the quality of life of those living with these illnesses and may contribute to restraining the growth in health care expenditure associated with them. The Center will support the design, development, implementation, and stage-advancement of pilot intervention projects, especially stage 1 pilots, proposed by researchers across the country and aimed at specific caregiving contexts.